Investigation of the Immune-Mediated Drug-Drug Interaction Potential of Immune Checkpoint Inhibitors

PROJECT SUMMARY/ABSTRACT
Immune checkpoint inhibitors have shown remarkable oncologic efficacy, but their clinical benefit is limited by
treatment-limiting adverse events. The efficacy of checkpoint inhibitors results from T-cell activation, which also
triggers increased production of pro-inflammatory cytokines. Pro-inflammatory cytokines are known to inhibit
hepatic drug-metabolizing enzymes, including members of the cytochrome P450 (CYP) family, and thereby
increase the exposure and potential for adverse events with co-administered CYP substrates. Since check-
point inhibitors are formulated as monoclonal antibodies that do not directly interact with CYP enzymes or drug
transporters, clinical drug-drug interaction studies were not performed during development. However, the po-
tential for clinically relevant drug-drug interactions with checkpoint inhibitors is supported by studies that have
found increased adverse events during co-administration with CYP substrates, including adverse events spe-
cific to co-administered CYP substrates. These findings suggest that adverse events during checkpoint inhibi-
tor therapy may be, in part, caused by drug-drug interactions that increase the potential for adverse events with
co-administered medications. Discovery of these novel drug-drug interactions will likely inform clinical strate-
gies to reduce adverse events during checkpoint inhibitor therapy and thereby enhance their clinical benefit.
The long-term goal of this research is to identify clinical strategies to manage adverse events during check-
point inhibitor therapy. The research aims of this proposal are (1) to determine the impact of checkpoint inhibi-
tor therapy on the metabolism of CYP probe drugs and the risk for adverse events with CYP substrate drugs
commonly prescribed to cancer patients and (2) to identify associations between pro-inflammatory cytokine
concentrations and CYP probe drug metabolism before and during checkpoint inhibitor therapy. To investigate
these aims, we will conduct a two-phase crossover clinical drug interaction study in which a cocktail containing
probe drugs for six CYP enzymes (CYP1A2, CYP2B6, CYP2C9, CYP2C19, CYP2D6, and CYP3A) is adminis-
tered to subjects before and after they initiate checkpoint inhibitor therapy. Metabolic ratios will be calculated
from concentrations of probe drugs and their metabolites to assess potential changes in CYP metabolism.
Changes in CYP metabolic ratios will be incorporated into physiologically-based pharmacokinetic models to
estimate the potential for changes in exposure and adverse events with CYP substrate drugs that are com-
monly prescribed to cancer patients with the potential for serious adverse events (e.g., citalopram, tramadol,
fentanyl). Pro-inflammatory cytokine concentrations will be assayed in both study phases to determine poten-
tial associations with CYP probe metabolic ratios. The expected outcomes of this proposal are to establish a
mechanistic understanding of checkpoint inhibitor-mediated drug-drug interactions that will (1) inform clinical
strategies to manage these interactions (e.g., therapeutic substitution to drugs with unaffected metabolic path-
ways) and (2) elucidate cytokine signatures to identify patients at highest risk for these drug interactions.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health since it is likely to contribute a mechanistic understanding for novel drug-drug interactions that contribute to treatment-limiting toxicities during immune checkpoint inhibi- tor therapy. This knowledge will be clinically impactful since it is likely to inform clinical strategies to identify pa- tients at highest risk for immune checkpoint inhibitor-related drug interactions and to prevent these drug inter- actions. The long-term goal of this translational research is to identify clinical strategies to enhance the safety, and thereby the clinical benefit, of immune checkpoint inhibitors.